Stanford Center for Clinical and Translational Research and Education

The mission of the Stanford CTSA is to transform clinical, translational, and science of translation research and education (CTSRE) at Stanford and across the CTSA consortium. The Stanford CTSA’s programs in CTSRE have been designed to extend from the earliest stages of the translational pipeline to the “final mile” of implementation science taking full advantage of the rich research and educational resources available at Stanford University. Stanford CTSA’s organizational structure, by design, promotes interdisciplinary educational and research opportunities and stimulates collaborative innovation and discovery. The vision of the Stanford CTSA is to a) accelerate the discovery and translation of treatments; b) increase substantially clinical trial and clinical research participation; and c) achieve this vision by leveraging real-world data systems and AI approaches to optimize translational research and the science of translation. In the next seven years, we believe the Stanford CTSA can best achieve this by capitalizing on our greatest strengths, namely a) training the next generation of clinical, translational, and science of translation researchers; b) implementing programs in the principles of the science of translation that will span all elements of our CTSA; c) developing, optimizing, and implementing innovative data science and health informatics infrastructure, methods, and tools to promote analysis of large-scale real world data to serve as the platform for the conduct of CTSRE, accelerating the translation of discoveries into improved health; d) sustaining, developing, enhancing, and implementing infrastructure, methods, services, and tools to support our entire CTSRE efforts locally and across the CTSA Hub; e) imbuing all Elements of our Stanford CTSA with science of translation principles, including rigor and reproducibility (SPORR) and team science, in support of our CTSRE mission. Finally, we aim to develop and employ innovative state-of-the- field evaluative approaches to determine the effectiveness of all our CTSRE efforts. We aim to do this locally, regionally, and nationally in collaboration with our networks and across the CTSA consortium.

Public health relevance
The overall vision of Stanford’s CTSA-supported research “Hub” is to transform clinical, translational, and science of translation research and education (CTSRE), by making CTSRE more effective and efficient at discovery, clinical, translational, and science of translation research and education to improve health. In the next seven years, we believe the Stanford CTSA can best achieve this vision by capitalizing on our greatest strengths, namely a) educating and training the next generation of clinical, translational, and science of translation researchers; b) developing and implementing across all elements of our CTSA the principles of the science of translation, including rigor and reproducibility (SPORR) and team science; and c) developing and implementing innovative, data driven, and clinical operational approaches to accelerate and scale our translational research and science of translation efforts. We aim to employ state-of-the-field evaluative approaches to determine the effectiveness and maximize the impact of our Stanford CTSA CTSRE efforts locally, regionally, nationally, and across our networks, including the CTSA consortium.